The role of macrophage subpopulations in the rejuvenation of fracture repair

The pace of bone repair slows with aging, increasing the chance of developing a delayed union or non-union.
These complications are treated with surgical procedures causing significant morbidity and even mortality,
especially in older adults. Here we will build on our previous work using heterochronic parabiosis (in which two
mice of a different age share a blood supply) showing that exposure to a young circulation and young
macrophage cells rejuvenates fracture repair in older mice. In our preliminary data we used cell lineage tracing
analysis and parabiosis experiments to determine the developmental source of macrophage in fracture repair,
and found these derived from a subpopulation of cells of yolk sac origin. Interestingly these cells reside in the
spleen and are recruited through the circulation during bone repair. As mice age, this subpopulation of cells
becomes depleted. In this proposal we study the role of this cell population and the factors they produce in the
rejuvenation of fracture repair by undertaking the following aims:
1) Identify the role of macrophages derived from yolk sac progenitors in the rejuvenation of
fracture repair. Heterochronic parabiosis in which these cells can be labeled or depleted will be investigated
to define the contribution of young cells from this population of macrophage cells that can improve the quality
of fracture repair in older animals.
2) Determine the function of genes expressed in unique macrophage subpopulations present in
young mice in bone repair: We used single cell RNA sequencing and found a unique subpopulation of
macrophages cells present in bone repair in only young animals. Mice lacking genes which encode for
secreted proteins in various macrophage populations will be used in heterochronic parabiosis to determine
their contribution to the rejuvenation of fracture repair.
3) Define how specific macrophage populations and the proteins they secrete alter
mesenchymal differentiation in fracture repair. Our prior work showed an important role for beta-catenin in
mesenchymal cell differentiation and in fracture repair rejuvenation. Here we will use in-vitro approaches to
determine how specific subpopulations of macrophage cells and the proteins they secrete alter mesenchymal
cell differentiation in cells from young and old animals. There will be an initial focus on beta-catenin, but an
unbiased approach will be used as well.
This proposed work builds on our prior studies of rejuvenation by heterochronic parabiosis in fracture
repair. It will address critical gaps in our knowledge about the mechanism responsible for the rejuvenation
phenotype driven by heterochronic parabiosis. Our work will also identify a novel therapeutic approach to
address a critical clinical problem in older patients, delayed fracture healing.

Public health relevance
The rate of bone repair slows with aging resulting in substantial morbidity and even mortality. This proposal will use heterochronic parabiosis (two mice of a different age share a blood supply) to identify the specific macrophage cell subpopulations and the proteins they secrete that are responsible for the rejuvenation. Our results will inform the development of new therapies to improve fracture healing in older individuals.